Xstrahl SARRP for Clinically Relevant Image-Guided Small Animal Radiation Studies

Project Summary/Abstract
Support is requested to purchase the Xstrahl Small Animal Radiation Research Platform (SARRP) which
would become the only image-guided small animal radiation delivery machine in the state of Alabama
and would dramatically enhance the preclinical research and translational potential at The University of
Alabama at Birmingham (UAB). Currently, there are 3 cabinet irradiators designated for animal and in
vitro use on campus at UAB and are utilized by ~500 users. However, none of these have image guidance
or focal irradiation potential. Indeed, irradiation is delivered using square field design and targets large
tissue regions requiring lead blocks for shielding animals from undesirable radiation. This is especially
problematic for the large number of investigators who rely on organ-specific radiation targeting such as
orthotopically implanted cancer xenografts, radiation-injury models, and similar models. Moreover, many
investigators rely on advanced small animal imaging modalities including CT, MRI, PET and
luminescence to non-invasively monitor tumors over time though these datasets cannot be used for
radiation treatment planning due to lack of image guidance in our existing cabinet irradiators which are
the preclinical equivalent of clinical radiation oncology from 50 years ago. This scenario is in stark contrast
the UAB department of radiation oncology which is a world leader in clinical radiation treatment delivery
having been part of many “firsts” including first clinical use of Varian RapidArc (volumetric modulated arc
therapy), first intrafraction motion review (“triggered imaging”) for lung cancer radiosurgery in the world,
first adaptive Varian Ethos radiation, first North American treatment using Varian HyperArc (Automated
multiple target radiosurgery optimization and delivery) co-developed by UAB, and first program in the
United States to use Varian Edge radiosurgery with virtual cone delivery to treat movement disorder
patients (e.g., essential tremor or tremor-dominant Parkinson’s patients). The acquisition of the SARRP
would provide true clinical beam delivery geometry with non-coplanar beam arrangements, dynamic
motorized variable collimator to adjust down to as small as 2 mm x 2mm field size, comprehensive animal
positioning in virtually any orientation with on-board cone beam computed tomography (CBCT), and
advanced image fusion from external imaging modalities such as bioluminescence, MRI and PET to
enable precisely focused radiation with image guided accuracy. These capabilities are in demand at UAB
yet remain unavailable. Therefore, the UAB School of Medicine and the O’Neal Comprehensive Cancer
Center are committed to supporting this S10 proposal by providing assurances for sustained success of
the SARRP as part of our successful Small Animal Imaging Core which will support ongoing projects and
foster new ones for our research community.

Public health relevance
Project Narrative: We are requesting support to purchase the Xstrahl Small Animal Radiation Research Platform (SARRP), which enables state-of-the-art image-guided small animal radiation treatment delivery with sub-millimeter accuracy and clinical beam delivery geometry useful for a wide range of researchers, particularly those in radiation oncology, medical physics, radiobiology, oncology and immuno-oncology. This instrument will be extremely valuable and provide a resource not available in the state of Alabama.